Training Program in Approaches to Address Social-Structural Factors Related to HIV Intersectionally (TASHI)

Project Summary
Four decades into the global HIV pandemic, HIV/AIDS remains a pressing public health challenge
contributing to almost 1 million deaths per year. Highly efficacious biomedical interventions have emerged,
including multiple modalities of long-acting anti-retroviral (ART)-based treatment and prevention. However, not
all people have equal access to these lifesaving technologies. Many of the same social-structural determinants
(e.g. structural racism, gender-based violence, intersectional stigma and discrimination) that have historically
constrained HIV protective behaviors, limit the potential for people and communities at the most marginalized
intersections of race, ethnicity, gender, socioeconomic status, and sexual and gender minority status, to benefit
from the real-world impact of these new technologies. Although there is increasing attention in the field to the
role of social-structural factors on prevention and treatment, substantial gaps exist about how best to
conceptualize, research, and develop effective interventions to address the influence of power structures and
systems on HIV prevention, treatment and care outcomes, including from an intersectional lens. The proposed
predoctoral Training Program in Approaches to Address Social-Structural Factors Related to HIV
Intersectionally (TASHI) will prepare the next generation of community-engaged researchers to rigorously
study and strategically intervene on these determinants to promote health equity and to end the HIV epidemic.
The program will leverage the multi-faceted strengths of the Departments of Prevention and Community
Health (PCH) and Psychological and Brain Sciences (PBS) at the George Washington University (GW) Milken
Institute School of Public Health (SPH) and the College of Arts and Sciences (CCAS), respectively, as well as
the GW Intersectionality Research Institute (IRI), the SPH’s Department of Epidemiology and the GW School
of Medicine’s Department of Psychiatry and Behavioral Sciences. Pre-doctoral trainees will undertake a
rigorous program of coursework including a solid foundation in critical theoretical frameworks (e.g., critical race
theory, intersectionality), multiple research methodologies (e.g., Community-Based Participatory Research,
mixed methods), and social-structural and multi-level intervention development and evaluation. Trainees will
participate in cross-cutting and integrative activities including a monthly seminar series, mentored research
projects, and community and stakeholder engagement rounds. Trainees will be supported by a group of 18
program faculty members with expertise in the social, structural and intersectional aspects of HIV and related
health outcomes. Proposed Co-Program Directors, Dr. Lisa Bowleg and Dr. Deanna Kerrigan, are recognized
leaders in the U.S. and global HIV response and both are executive committee members of the District of
Columbia Center for AIDS Research (DC CFAR), which will serve as a foundational platform for TASHI.

Public health relevance
Project Narrative The goal of the proposed predoctoral training program is to prepare the next generation of HIV researchers to improve health equity and HIV prevention, treatment and care outcomes by: (1) developing theoretical competency in social-structural, intersectional and critical health equity approaches to HIV; (2) using these theoretical approaches to design and conduct rigorous research; (3) formulating strategic interventions grounded in social-structural and intersectional approaches; and (4) engaging equitably with the intersectionally diverse communities disproportionately affected by HIV, throughout all stages of research and intervention.